Clinical Optimization of Ultrasonic Drug Delivery Technologies for Underserved Minority US Veterans in Chronic Pain

Project Summary:
Narcotic use in pain management of underserved minority populations and minority United States veterans has
played a major role in the ongoing opioid crisis. According to the NIH, veterans are more susceptible to opioid
addiction and are 40% more likely to suffer from severe chronic joint pain then non-veterans. Over the next
decade, the percentage of minority veterans will increase from 23% to 34% and is expected to rise. This shift of
racial and ethnic minorities directly correlates to the growing demographics of minority active-duty soldiers that
make up over 40% of our nation’s military forces. The federal government considers the 18.2 million veteran and
42 million non-veteran minority Americans to be "potentially vulnerable patient populations” with health disparities
particularly related to joint diseases care. Osteoarthritis (OA) is one of the most common of these joint diseases
affecting the entire US population, and of considerably higher 19-fold incidence and prevalence in the service-
disabled veteran population. Although the disease itself does not appear to occur more frequently in minorities,
its effects and progression are more severe. This is especially true among minorities with arthritis, 36.7% of
Black patients and 35.5% of Hispanic patients reported severe joint pain compared to only 23.0% of non-Hispanic
Whites. The economic burden of veterans with OA is estimated to approach or exceed $60 billion annually due
to longer life expectancies. Arthritis is also a significant economic and health burden in the United States at large
which is estimated to exceed $394 billion in healthcare costs by 2030. In our SBIR HEAL Phase I, we developed
a wireless long-duration low-intensity ultrasound NSAID-enhanced (2.5% diclofenac) sonophoresis system for
use by the underserved OA population. We first demonstrated that the sonophoresis technology could increase
tissue penetration of NSAIDs by 3.8x compared to standard of care (p<0.01). Secondly, the miniature device
was evaluated in a 25-subject human-factors study, 54-subject diathermy study and a 52-subject OA clinical
study on patients with radiographically confirmed mild to moderate knee OA. In 8-weeks of daily 4-hour use,
symptomatic pain was significantly reduced by 3.43 point (55%) NRS (n=34, p<0.0001) versus 1.00 point (22%)
NRS (n=18, p=0.0847) for subjects treated with topical diclofenac pain cream. Over 98% of the study population
found the device easy to use and would continue treatment for their knee OA symptoms. For this Phase II HEAL
renewal application (1) First ZetrOZ Systems will refine the design and optimize the wireless sonophoresis
technology for shelf-life stability and device functionality/usability by the veteran and aging population. A series
of regulatory testing standards including sensitization, cytotoxicity, packaging/formulation stability,
biocompatibility, microbial growth, shelf-life and home-use will be completed on the wireless sonophoresis
system. Additionally, a porcine animal model with histopathology and pharmacokinetics will be completed to
verify the safety profile of the technology. (2) ZetrOZ Systems will complete a 24-week, 3-arm, multi-site,
placebo-controlled, randomized, efficacy study to expand upon our Phase I study by examining the health
benefits and commerciality of the sonophoresis technology in 300 patients enrolled at three ethnically diverse
locations. The primary outcome of the study will be pain score, evaluated daily using the numerical rating scale
(NRS). Baseline NRS score will include the first two weeks of the study without intervention. The intervention
phase will separate three demographically equivalent groups of 100, assigned to use either the
medicated/unmedicated sonophoresis technology or standard 2.5% diclofenac topical cream daily self-applied
for 24 weeks. The proposed combination therapy has the potential to deliver a safe, effective, and conservative
treatment approach for OA across the minority, veteran, and aging populations.

Public health relevance
Project Narrative: This project proposes to clinically validate and commercialize wireless ultrasonic drug delivery technology for underserved minorities, minority United States Veterans and rural patients with chronic knee pain. The technology has been evaluated in the laboratory and the clinical setting with positive results. We will now finalize regulatory testing of the wireless system, and clinically evaluate the therapy in a multi-site long-term clinical efficacy study.